Selective galactosylceramidase ablation to study the pathogenesis of Krabbe leukodystrophy

Krabbe leukodystrophy (KD) is a fatal neurodegenerative lysosomal storage disorder caused by deficiency of galactosylceramidase (GALC) that affects both central and peripheral nervous systems. KD manifests in infants in the first few months of life and presents with severe irritability, muscle rigidity and motor deterioration, which quickly progresses to overall clinical decline and death within months. Unfortunately, there is no cure for KD and we have a limited understanding of KD pathogenesis. Hematopoietic stem cell transplantation (HSCT) partially attenuates the course of KD only if performed before the onset of symptoms, presumably because stem cell derivatives secrete GALC that is uptaken by myelinating glia via the mannose-6-phosphate receptor, so called cross-correction. However, it is not clear how efficient the cross-correction happens in vivo, if only myelin-forming glia need to be corrected and at which developmental stage. Furthermore, accumulation of the lipid psychosine due to GALC deficiency contributes to KD by killing myelin-forming glia and neurons, but the relative importance of psychosine, its origin and the sequence of pathogenic events is unclear. We recently developed a conditional Galc floxed mouse and found that: 1) A KD-like clinical phenotype is much delayed (~25 days) when Galc ablation is induced ubiquitously [Galc-iKO] after postnatal day (P) 6, as compared to the induction at P4 or before, indicating there may be a narrow critical period of vulnerability for the induction of pathology. In addition, despite near-total ablation of GALC activity upon recombination, substantial GALC activity returned in the moribund Galc-iKO brains, emphasizing the need for GALC expression at earlier times; 2) Oligodendrocyte (OL)-specific Galc conditional knockout [Galc-CKO] results in a phenotype that includes tremor, wasting, kyphosis, motor defects, demyelination and mild axonal degeneration, but that is not as severe as Galc-iKO mice, suggesting that Galc deficiency in OLs may be not sufficient to trigger a complete KD phenotype; and 3) GALC uptake is less efficient in Galc-null cells in vitro, and surrounding WT cells provides minimal GALC to Galc-deficient OLs in vivo, indicating inefficient cross-correction of GALC. We propose 3 Aims to determine; 1) the critical period of vulnerability for the initiation of KD pathology, 2) the most important cells in the progression of KD pathology, and 3) the efficiency of cell-specific cross-correction of GALC. By combining a series of in vitro experiments with the comparison of cell-specific, time?specific and constitutive deletion of Galc in vivo, we will test the following 3 hypotheses that derived from our preliminary data and from the clinical experience: 1) GALC has a specific and important role during a narrow critical period that is significantly before clinical symptoms appear; 2) any brain cell can in principle produce psychosine or be the target of toxicity; 3) HSCT fails to cure KD due to inefficient cross-correction of GALC. Our results will help to understand the disease mechanisms of KD and the limitations of HSCT, which will allow the development of better therapies for KD and similar lysosomal, neurodegenerative and demyelinating diseases.

Public health relevance
Krabbe leukodystrophy (KD) is a progressive and fatal neurologic lysosomal storage disorder that usually affects babies and causes death before two to three years of age. Hematopoietic Stem Cell Therapy is not sufficient to improve the long-term survival of most patients with KD and the outcome of patients, with or without therapy, remains dismal. Using our newly developed KD animal model, we will discover the critical time that the disease starts and identify which cell type needs to be targeted with therapy.